Evaluating a novel policy to increase access to nicotine replacement therapy in community retailers

ABSTRACT
There is a strong rationale to prioritize tobacco control policy interventions in communities at high risk for
tobacco product exposure, lower access to pharmacies, and associated health disparities. Policy efforts to
increase access to NRT by requiring its sale and signage in community retailers could address multiple threats
to public health. To date, there have been limited efforts to increase NRT availability in the tobacco retail
environment. Growing out of the recognition that convenience stores sell most tobacco products but little NRT,
in 2022 NJ became the first U.S. state to require tobacco retailers to sell NRT. While a law requiring NRT at
the point of sale holds promise to further reduce tobacco use, the extent to which this new law could have a
positive equity impact is unknown. This exploratory R21 project uses a mixed methods approach to
understand the implementation and short-term impact of a new statewide NRT law, seeking to expand the
evidence base with a focus on racial/ethnic groups in the context of a diverse tobacco environment.
Specifically, we will: 1) determine whether NRT compliance varies by neighborhood characteristics using store
audits and conducting spatial analyses to examine associations between compliance and neighborhood
demographics and tobacco retailer density, and 2) explore short-term indicators of the NRT law’s impact by
examining trends in NRT product sales and NJ Quitline calls between 2021 and 2023. The relevance of the
proposed research to public health is its ability to improve existing and future NRT policies in ways that could
promote health equity and reduce tobacco-related disparities.

Public health relevance
PROJECT NARRATIVE In 2022, New Jersey became the first U.S. state to enact a law requiring sales of nicotine replacement therapy (NRT) in licensed tobacco retailers. The extent to which such a law could further reduce tobacco use, with a positive equity impact, is unknown and the proposed research seeks to examine compliance with the NRT law and its association with community demographics, sales of NRT using retailer scanner data, and engagement with NJ Quitline. Study results may inform public health and tobacco regulatory policies and enhance future longitudinal research.